Longitudinal Impacts of Pandemic-Induced Disruptions on Adolescent Siblings' and Parents' Alcohol Use: A Family Life Course Perspective

PROJECT SUMMARY/ABSTRACT
In March 2020, the COVID-19 pandemic abruptly disrupted the daily lives of adolescents and their families in
the United States. Emergency school and community closures confined children and adults together in their
homes with greatly limited access to other supportive adults and institutions. Adolescents' involvement in
developmentally-normative contexts was interrupted. This crisis evolved into a chronic, relapsing and remitting
state of life with intensities that varied dramatically between families and communities as well as across weeks,
months, and now years. As such, there is a critical need to understand how these disruptions affected
adolescents' and parents' short- and long-term health, and in particular, their alcohol and other substance use.
The present study addresses this need through the combination of extant data analysis and prospective data
collection. Rooted in life course developmental theory, we will explore the implications and developmental
timing of pandemic-induced disruptions and stressors for adolescents' and parents' alcohol and other
substance use in the ongoing accelerated longitudinal Parent and Adolescent Sibling Study (PASS). PASS
includes 1364 adolescent siblings and their parents; adolescents ranged in age from 10 to 17 (grades 5-10)
during the pre-pandemic period at Wave 1 (2019). Families in PASS provided/will provide survey data three
times over two consecutive years during the pandemic (Wave 1.5, May-June 2020; Wave 2, Fall 2020; Wave
3, Fall 2021). With the proposed Wave 4 (Fall 2022), PASS's multi-wave (5 total assessments across four
years), multi-family member longitudinal study will capture the entire arc of the COVID-19 pandemic. Testing
the life course principle of linked lives, we will investigate the associations between multiple family members'
alcohol and substance use patterns throughout the pandemic period. This focus on the family context is critical
given its fundamental importance for youth's alcohol and other substance use was further amplified during
shutdowns/restrictions as it has been the primary site in which pandemic stressors were experienced. Finally,
we will identify risk and protective factors (both between-person and within-family) that moderate the influence
of pandemic-related disruptions on youth's alcohol and other substance use patterns and trajectories. The
aims will be tested using a structural equation (SEM) framework. This flexible analytic procedure is
advantageous as it can model longitudinal data which are nested within individuals as well as data from
siblings which are further nested within families. SEM permits modeling of individual differences in change
patterns (including non-linear patterns), attributes those differences to both time-varying and time-invariant
covariates, and efficiently accounts for missing data. Ultimately, understanding how adolescents and parents
suffered, adapted, and coped with pandemic challenges is key for supporting recovery from this era, for
understanding response to economic crises and natural disasters, and anticipating long-term trends in alcohol
and other substance use among the current cohort of adolescents.

Public health relevance
PROJECT NARRATIVE Rooted in life course developmental theory, the proposed study examines how disruptions related to the COVID-19 pandemic are associated with immediate and longitudinal changes in adolescents' and their parents' alcohol and other substance use. Testing life course principles about developmental timing, linked lives, and cumulative disadvantage, we will specifically investigate how the timing of COVID-19 pandemic- induced disruptions, other family members' substance use patterns, and youth's personal, dispositional, and relational qualities shape teens' alcohol and other substance use trajectories over the arc of the pandemic. Understanding how adolescents and parents suffered, adapted, and coped with pandemic challenges is critical for developing responses to other public health emergencies, including economic crises and natural disasters, for anticipating long-term trends in alcohol and other substance use among the current cohort of adolescents, and for supporting recovery from this era.